Multidisciplinary Training in Environmental Toxicology

The Environmental and Integrative Toxicological Sciences (EITS) Training Program at Michigan State University
(MSU) produces independent investigators who have a strong understanding of a biomedical basic science, a
foundational knowledge of environmental toxicology and outstanding training in conducting mechanistic and
translational research. To earn the EITS dual major, predoctoral trainees must fulfill the Ph.D. requirements of
their basic biomedical doctoral program as well as coursework, research and interactive requirements of the
EITS. The EITS requirements include a mixture of courses focused on didactic, toxicology-oriented material,
training in the handling and processing of big data, and introduction to emerging environmental health issues.
This coursework, career development opportunities and multidisciplinary activities provided by the Institute for
Integrative Toxicology (IIT), Center for Research on Ingredient Safety (CRIS) and the MSU NIEHS P42
Superfund Research Program Center (SRPC) impart a wider scope of knowledge and experiences than is
available within traditional basic science programs alone. Once completed, EITS trainees are awarded a degree
that recognizes the dual major (e.g., Biochemistry and Molecular Biology-Environmental Toxicology). The
postdoctoral training program involves not only conducting research in the laboratories of the training faculty but
also gaining additional environmental toxicology experience and career-building opportunities. These additional
opportunities are facilitated through participation in IIT and university-wide activities, as well as those offered by
individual departments and the MSU Graduate School. The career paths of all EITS trainees are facilitated by
the creation and implementation of an individual development plan (IDP). EITS graduates are uniquely trained
to conduct independent and collaborative research in challenging areas that address complex environmental
toxicological problems and go on to become leaders in academia, government, and industry. This training is
facilitated by an attentive faculty that primarily come from seven basic science Ph.D. programs (Biochemistry
and Molecular Biology, Cell and Molecular Biology, Genetics and Genome Sciences Program, Microbiology and
Molecular Genetics, Pharmacology and Toxicology, Molecular, Cellular, and Integrative Physiology and
Neuroscience). Research for trainees is focused on understanding mechanisms of toxicity caused by exposure
to various environmental pollutants such as planar aromatic hydrocarbons, metals, and inhaled particles. Their
research spans various organ systems, encompasses gene-environment interactions and strives to translate
findings from model organisms and cell culture to human relevant endpoints. This application requests support
of seven predoctoral and two postdoctoral trainees, thereby continuing a highly effective multidisciplinary and
interactive training program. The EITS combines formal and informal approaches to prepare graduates for
leadership roles in mechanistic and translational research that aims to advance our understanding of adverse
outcomes from exposure to environmental chemicals.

Public health relevance
PROJECT NARRATIVE There is growing realization that disease susceptibility is a complex interaction between genetics, age, lifestyle choices, and environmental exposure. Training interdisciplinary scientist that can deal with this complexity, including analyzing the large amount of data necessary to quantify the different biological facets, is required if we are to develop interventions, cope with fallout from environmental accidents, and accurately inform public health officials. This predoctoral and postdoctoral training program, in collaboration with its experienced and research-intensive faculty, produces scientists with the skillset necessary to make a positive impact in addressing environmental issues using state-of-the-science mechanistic and translational toxicology.